MONITORING PEDIATRIC HEAD INJURY MODELS IN PIGLETS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Traumatic brain injury (TBI) is a leading cause of childhood morbidity and mortality in the United States, with an annual rate of approximately 200 per 100,000 children requiring hospitalization. The increasing monetary costs result not only from the acute intensive care for these patients but also from long-term care that is often necessary. Brain injuries in these patients result from both the primary trauma and secondary insults such as reductions in cerebral blood flow, derangements in cerebral metabolism, and the ensuing ischemic injuries that continue to progress well after the traumatic event. Optimal therapeutic efficacy thus requires knowledge of cerebral blood flow, oxygen supply, and oxygen consumption in patients after TBI.